Remodeling Chromatin and the Tumor Microenvironment: Direct Oncogenesis and Therapeutic Targeting

ABSTRACT
A commonly recognized mechanism of immune evasion in solid tumors is diminished MHC and antigen
presentation. Most cases retain some MHC expression, and strategies for upregulation may enhance
immunogenicity. Melanocyte development is regulated by the master transcription factor MITF which targets
virtually all components of the pigmentation machinery. This pathway is vulnerable to protein aggregation (e.g.,
after UV/tanning). MITF appears to simultaneously target certain “quality control” factors that protect against
misfolded species. We recently discovered MITF’s direct transcriptional regulation of a protease gene called
DDI2 which we found to participate in ER “quality control.” Unexpectedly, among the proteins degraded
downstream of DDI2, are MHC-I and MHC-II, leading to decreased antigen presentation. We believe this occurs
because peptide-MHC complexes may be “mis-perceived” as unfolded due to thermodynamic features of
peptide-MHC interactions. Importantly, we found that DDI2 suppression by gene knockout or drug, upregulates
MHC-antigen levels, producing functional stimulation of antigen-specific T cell activation, and enhanced tumor
killing both in vitro and in vivo (with anti-PD1) in multiple tumor types. The active sites of DDI2 and HIV-1 protease
coincidentally bear striking homology, and two FDA approved HIV protease inhibitors also block DDI2 (multiple
others do not). One of these, Nelfinavir (NF) is a well-tolerated drug, and potently phenocopies DDI2 knockout.
The combination of highly defined human and mouse melanoma models, which include antigen-specific MHC-
restricted matched CD8 and CD4 T cells, coupled to deep cellular, molecular, proteomic, immunophenotyping,
and tumor treatment assays, permit us to propose the following studies: Specific Aim 1 expands our evidence
that DDI2 suppression (knockout or drug) enhances anti-PD1 activity, by testing in complementary mouse
models, combinations of DDI2-KO or NF with anti-CTLA4, anti-LAG3, and 3-way combinations together with
anti-PD1, as these are FDA approved treatments. All will be scrutinized with detailed immunophenotyping,
MHC/peptidomics, and other expression assays. Specific Aim 2 examines immunopeptidomics: isolation and
sequencing of MHC-associated peptide antigens. This tests which antigenic peptides are increased by DDI2
suppression, as we hypothesize that DDI2 suppression rescues a more diverse peptide population, and may
boost T cell diversity (also to be tested by TCRseq). Specific Aim 3 probes MITF’s demonstrated direct
regulation of DDI2, predicting a pathway that links MITF to MHC-antigen levels and, thereby, to immune evasion,
which would be a novel and druggable oncogenic mechanism. Specific Aim 4 dissects data from >200 single
cell RNAseq of anti-PD1-resistant patients plus additional anti-PD1 sensitive ones, where we will determine DDI2
expression (RNA and protein) and use multiplex immunofluorescence to quantify MHC-I and -II levels— linked
to microenvironment immune populations and clinical annotation of responses. The goal is to determine features
of patients most likely to benefit from DDI2 suppression for enhanced immunotherapy responses.

Public health relevance
Narrative Project 1 examines the role of DDI2 as regulator of a pathway that suppresses levels of MHC- antigen presentation complexes at the tumor surface, thereby promoting immune evasion. Because DDI2 is transcriptionally targeted by the melanoma oncoprotein MITF, we will test the hypothesis that the MITF-DDI2 axis represents a novel oncogenic immune modulation mechanism. We will also scrutinize the antigenic repertoire regulated by DDI2 via immunopeptidomics to test the hypothesis that pharmacologic DDI2 suppression would stimulate both quantity and diversity of presented antigens by melanoma cells.